Impact of Alcohol on Aging Skeletal Muscle

Project Summary/Abstract
Aging-related sarcopenia includes the loss of muscle mass and strength/function, which impairs
mobility, increases falls, decreases independence and quality of life, and increases mortality. Alcohol use is
among the lifestyle factors that may influence the development and progression of aging-related sarcopenia,
as it promotes skeletal muscle myopathy in adults at high doses, and at low doses may improve mitochondrial
function. Cross-sectional and prospective cohort studies indicate that high doses of alcohol are associated with
greater incidence of sarcopenia while low to moderate intake is associated with maintenance of physical
function and grip strength, as well as decreased frailty. As this dose dependent relationship has never been
investigated experimentally in a well-controlled setting, the objective of this proposal is to develop and
characterize a pre-clinical mouse model of aging to determine the dose- and sex-dependent effects of alcohol
on aging-related sarcopenia. Relatedly, our long-term goal is to then investigate the potential paradoxical
properties of alcohol on aging muscle while focusing on mechanisms that can be targeted pharmacologically to
either limit or mimic the effects of each dose of alcohol. Specific Aim 1 will determine the dose-dependent
effects of alcohol on the development and progression of aging related losses in skeletal muscle strength and
performance, while Specific Aim 2 will investigate the effects of alcohol on aging related changes in skeletal
muscle size and composition. These research questions will be addressed using middle aged (12 mo. old)
male and female mice consuming either a high (15%v/v) or low (3.5%v/v) dose of alcohol in their water daily
until reaching old age (~30 mo. old). Every 3 months performance tests and measurements of frailty, metabolic
rate and cage activity will be completed. At 12 (baseline), 18, 24 and ~30 months of age, in-situ and ex vivo
skeletal muscle force production and fatigability will be quantified on muscles of the lower leg. Follow-up
assessments will include measurement of myofiber cross sectional area per fiber type and deposition of
collagen and fat in the muscle. This will be the first investigation of the dose-dependent effects of alcohol on
sarcopenia and will lay the foundation for future mechanistic investigations to determine how alcohol influences
sarcopenia risk and aging associated changes to skeletal muscle in a sex-specific manner.

Public health relevance
Project Narrative Intake of excessive amounts of alcohol over a prolonged period is detrimental to health and represents a major public health issue, while small amounts of alcohol may be beneficial or not affect health. Aging is also a significant public health concern, but it is unknown whether drinking alcohol across the lifespan makes aging-related changes in skeletal muscle better or worse. The goal of this research is to determine if a small or large amount of alcohol drank throughout adulthood and into old age affects skeletal muscle health so appropriate dietary recommendations related to alcohol use can be implemented to reduce the incidence of falls, disability, and mortality in the elderly.